Regulation and tumorigenesis of non-classical RAS oncoproteins - Resubmission

PROJECT SUMMARY
Oncoproteins drive tumor development and aggressive growth by dysregulating the signaling pathways involved
in cell growth, survival, and proliferation. Targeting oncoproteins directly, or their downstream pathways, has
resulted in novel therapies currently being used for the treatment of different cancer subtypes.
The RAS family of guanosine triphosphatase (GTP) hydrolases (GTPases) are a group of oncoproteins, that
have roles in cancer initiation, progression, and resistance to therapies. Furthermore, mutations in genes
encoding classical RAS proteins are very frequent in cancer. RAS proteins cycle between a guanosine
diphosphate (GDP) inactive form and a GTP active form. In its GTP-bound conformation, RAS proteins promote
activation of downstream signaling pathways that contribute to the growth and proliferation of cells. This
nucleotide cycle is assisted by accessory proteins that catalyze the loading or hydrolysis of GTP and
dysregulation of this mechanism is also frequent in cancer.
Emerging evidence has shown that non-classical RAS proteins also play critical roles in cancer biology; however,
their mechanisms of regulation and tumorigenesis are not well-understood and differ from classical RAS proteins.
We have recently discovered a novel mechanism of regulation of the non-classical RAS proteins RIT1 and MRAS
that is mediated by ubiquitination and proteasomal degradation of the inactive GDP-bound form. Our work
identified LZTR1, a novel protein that binds RIT1 and MRAS and forms a complex with the E3 Ubiquitin ligase
Cullin-3 (CRL3LZTR1). Cancer-associated mutations in RIT1 or LZTR1 disrupt their interaction and lead to the
accumulation of non-classical RAS GTPases and activation of downstream signaling.
In this application, we propose to study critical aspects regarding the regulation of this novel complex, its
contribution to tumorigenesis, and potential pharmacological strategies to restore protein degradation.
In Aim 1, we will use biochemical and structural approaches to understand the determinants of LZTR1 selectivity
towards the non-classical RAS GTPases RIT1 and MRAS and the function of its protein domains.
In Aim 2, we plan to elucidate the signaling mechanisms that regulate CRL3LZTR1 activity in cells and how these
pathways can contribute to the resistance to specific targeted therapies.
In Aim 3, we will develop novel mouse models that are driven by an oncogenic RIT1 mutation that is resistant to
LZTR1-mediated proteasomal degradation and analyze the molecular signatures of these tumors. In addition,
we will develop proof-of-concept pharmacological treatments for RIT1-driven cancers.
Overall, our project will address a major knowledge gap in the mechanisms of regulation of non-classical RAS
oncoproteins and will provide novel preclinical models and therapeutic strategies for these cancers. The work
described in this application is the first step to develop mechanism-based and precise medicines for targeting
these oncogenic pathways in cancer.

Public health relevance
PROJECT NARRATIVE The family of RAS oncoproteins drive tumor growth and have been widely characterized in cancer; however, non-classical RAS proteins remain poorly studied despite their relevance in this disease. We have discovered a novel cellular mechanism that results in the degradation of the non-classical RAS oncoproteins RIT1 and MRAS and it is mediated by a complex that includes the protein LZTR1. Our work into this mechanism will lead to novel insights into the regulation of non-classical RAS oncoproteins, the relevance during tumor formation, and potential innovative therapeutic approaches.